Role of TLR4 and the microbiome in colitis associated neoplasia

ABSTRACT
We seek to understand the progression from inflammation to neoplasia in patients with inflammatory bowel
disease (IBD). Often patients are diagnosed with dysplasia and undergo colectomies even though they will
never develop cancer. The focus of our studies has been the link between intestinal bacteria and innate
immune signaling leading to colitis-associated neoplasia. Toll-like receptor 4 (TLR4) recognizes LPS and other
endogenous ligands present in the inflamed colon. Our group has shown that TLR4 is overexpressed in
inflamed and dysplastic tissues of ulcerative colitis (UC) patients. Using transgenic and knock-out mice, we
have shown that intestinal epithelial expression of TLR4 engenders a colitogenic microbiome capable of
transmitting inflammation. Mice with constitutively active TLR4 in epithelial cells show dramatically increased
epithelial proliferation and increased colonic tumors (AOM-DSS). Our preliminary data demonstrate that cancer
stem cells from these tumors have a very distinct transcriptional profile compared to tumors in WT mice. We
also show that TLR4-driven tumors have enhanced recruitment of tumor supporting myeloid-derived
suppressor cells (MDSCs). TLR4-driven tumors have dramatic upregulation of NADPH oxidases and enhanced
production of H2O2. H2O2 and other reactive oxygen species have several biological functions, including control
of cell proliferation and microbial populations. In the current proposal, we hypothesize that dysregulation of
TLR4 induces redox signaling, promoting stem cell activation and leading to selection of a tumorigenic
microbiome. We further hypothesize that the dysbiotic microbiome activates MDSCs to promote CAC. This is
pursued in the following specific aims: 1) Analyze the role of TLR4-mediated redox signaling on cancer
stem cell activation in CAC. We will use our diverse animal models for TLR4 and the NADPH dual oxidase 2
(Duox2) to define how redox signaling participates in activation and survival of cancer stem cells during TLR4-
driven tumorigenesis. 2) Interrogate the inter-relationship of TLR4-mediated redox signaling on mucosal
dysbiosis and the consequences of dysbiosis in tumorigenesis. We will use our animal models and
metagenomic sequencing to investigate how redox signaling through Duox2 participates in TLR4-mediated
dysbiosis, and will use mucosa-associated microbial transplants to test the tumorigenic effects of this
microbiota in germ-free mice. 3) Dissect the role of TLR4 in shaping the response of MDSCs to the
resident microbiome during tumorigenesis. We will use dual RNA sequencing of bacterial and host RNA
from tumor-associated MDSCs and MDSCs from UC patients to determine the interplay between the resident
microbiota and tumor-promoting gene expression in MDSCs. We will also functionally characterize the pro-
tumorigenic responses of MDSCs upon TLR4 stimulation including cytokine, chemokine, and H2O2 production.
The work proposed herein will provide the mechanistic justification for subsequent human studies to target
TLR4 or downstream signaling molecules as a means to halt progression from UC/inflammation to dysplasia
and dysplasia to cancer.

Public health relevance
NARRATIVE Ulcerative colitis patients have an increased risk of colon cancer because the constant inflammation of the colon causes damage to the intestinal lining. We believe that the bacteria in the colon and the immune system feed off each other to cause inflammation and more damage. We will use the most up to date methods and human specimens to tease apart how the immune system and the gut bacteria conspire to cause pre-cancer and cancer.